Orally active MMP inhibitor for the treatment of bone cancer pain

? DESCRIPTION (provided by applicant): Aquilus Pharmaceuticals, Inc. proposes to evaluate the effects of a proprietary matrix metalloproteinase (MMP) inhibitor, AQU-118, for blocking mechanical allodynia and bone & nerve compression pain in a rodent model of bone cancer. The goals for Phase I are to scale-up the synthesis of AQU-118, determine its oral pharmacokinetics (PK) and target tissue penetration, and determine its efficacy in a mouse bone cancer pain model via NCTC 2472 fibrosarcoma cell implantation. The primary read-outs will be measuring mechanical allodynia and motion induced pain. The secondary read- out will be to measure the extent of bone density loss and tumor growth. A follow-up biomarker and gelatin zymography analysis will be performed to determine if any behavioral changes observed from the animal model as a result of dosing with AQU-118 correspond to changes in metalloproteinase (MMP-2, MMP-9), cytokine (IL-1 , IL-6) & EphB1/EphrinB1 levels in serum and/or target tissue. The ultimate goal of the proposed work is to evaluate whether a matrix metalloproteinase inhibitor can be used to significantly reduce bone cancer pain and bone density loss without the side-effects of euphoria, tolerance and addiction.

Public health relevance
PUBLIC HEALTH RELEVANCE: Over 3000 people in the US are diagnosed with bone cancer, a majority of which will suffer severe pain as a consequence. Morphine remains the gold standard for the management of bone cancer pain despite having the significant side effects of tolerance, hyperalgesia and addiction. Aquilus Pharmaceuticals will test a novel inhibitor of a group of proteins that have recently been discovered to be involved in the initial inflammatory cascade resulting from bone cancer and neuropathic pain. A primary objective for Aquilus will be determine if this inhibitor can block pain in a rodent bone cancer pain model when given orally. A secondary objective will be to see if this inhibitor can reduce the rate of bone density loss due to cancer. If the project is successful, Aquilus Pharmaceuticals will be able to rapidly bring to the clinic a first in class drug that can block pain and bone loss associated with bone cancer.